Oregon BIRCWH: Scholars in Women's Health Research Across the Lifespan

Project Summary
This application is for competing renewal of the “Oregon BIRCWH: Scholars in Women's Health Research
Across the Lifespan” program. The overarching goal of our program is to recruit early-stage research faculty
from diverse backgrounds and disciplines, and develop them into scientific leaders who advance
interdisciplinary research in women's health and sex/gender-based research across the lifespan. The Oregon
BIRCWH has successfully trained 31 scholars who have received nearly $268 million in research funding
($115M increase from the last cycle), published over 1,400 peer-reviewed papers (doubled from last cycle),
and received endowed chairs and leadership roles in academics, industry and federal agencies. The unifying
theme of our program centers on the lifespan. Scientifically, Oregon BIRCWH Scholars and mentors lead
innovative, cutting-edge research across the entire lifespan from in utero and childhood to reproductive age
and late adulthood. Professionally, we recognize that networks and mentoring are critical supports for BIRCWH
Scholars throughout their academic lifespan. Scholars are selected through a highly competitive process. The
Oregon BIRCWH provides: 1) a robust mentored research and training infrastructure that promotes
interdisciplinary women's health and sex/gender differences research; 2) a welcoming, diverse, and inclusive
culture of collaboration and mentorship that promotes team science; and 3) a proven process to recruit, train,
and support diverse faculty who become national research leaders and expand the footprint of women's health
and sex/gender differences research. The Oregon BIRCWH prioritizes the goal of gender, racial, ethnic, ability,
and sexual orientation equity and diversity in science, professional development, and culture. We leverage our
distinguished programs and unique position as the only institution-wide K12 career development program
specifically dedicated to women's health and sex/gender differences to advance the trans-NIH ORWH strategic
plan for women's health research at institutional, regional, and national levels. Innovative expansions
proposed in this renewal include: 1) enhancing our campus-wide approach to recruitment and expansion of the
BIRCWH infrastructure to attract, support, and nurture even greater diversity; 2) drawing upon the legacy and
success of the program to introduce a core curriculum specifically tailored to the unique needs of BIRCWH
Scholars, called “BIRCWH Essentials by BIRCWH Alumni”; 3) leading inter-institutional conferences and
events to promote innovative thinking, networking, and collaboration; and 4) developing “BIRCWH Connect”, a
social media platform to support an actively engaged BIRCWH community across the country. The broad
institutional support, highly interdisciplinary environment, committed leadership, and deep dedication to
diversity, equity and inclusion position the Oregon BIRCWH to drive the future of women's health and
sex/gender differences research for years to come.

Public health relevance
Project Narrative The diverse across overarching goa l of this training program is to foster the development of early-stage research faculty from backgrounds and disciplines to develop leaders in women's health and sex/gender-based research the lifespan. We apply the lifespan approach to faculty career development and science preparing BIRCWH Scholars to lead new initiatives advancing NIH ORWH research priorities.